Training and Research on Severe Malarial Anemia

PROJECT SUMMARY
This proposal is the fourth renewal of our continuously funded Global Infectious Disease training grant that
established the International Malaria Training and Research Program (IMTRP) in 2002 (PD/PI, D. Perkins).
While a central theme of our research training platform has focused on severe childhood malaria, the IMTRP
has progressively expanded to include additional leading infectious diseases in Kenya. Our training approach
utilizes advanced scientific instruction in thematic core areas with general principles that can be applied to
combat a multitude of infectious diseases. This strategy offers advantages for creating long-term capacity
building to address the challenges presented by both ongoing and newly emerging high-burden infectious
diseases. Based on current and future needs identified by our Kenyan partners, we propose advanced research
training in: (1) Host-Pathogen Dynamics, (2) Therapeutic Discovery, and (3) Disease Modeling. Training will be
provided to address the ongoing challenges of malaria and the emergent crisis due to COVID-19. The next
phase of our activities will continue long-standing international partnerships between the University of New
Mexico (UNM), Los Alamos National Laboratory (LANL), Masinde Muliro University of Science and Technology
(MMUST), Kenya Medical Research Institute (KEMRI), and West African Centre for Cell Biology of Infectious
Pathogens (WACCBIP, Ghana), along with a new partner, Kirinyaga University (KyU). During the current funding
cycle, trainees were highly prolific in generating peer-reviewed manuscripts (32) and presenting at international
meetings (61). Moving forward, we propose long-term training (12 months) in Kenya for junior faculty at our
partner institutions, along with postdoctoral fellows, and doctoral students (4 per year in each category). The
IMTRP has created a highly successful pipeline of diverse trainees to continue in these career development
tracks towards independent investigator status. A competitively awarded re-entry grant will be provided each
year to support junior faculty in this important transition. We also propose medium-term training for specialized
mentoring in advanced methodologies (technical and data analytic) for 3-4 trainees per year (6 months) in the
US (UNM and/or LANL) and for 2 trainees per year (2-3 months) at WACCBIP. Short-term, in-depth training (2-
3 days) will also be offered annually on specialized research methodologies in the thematic three training areas
and requisite research competencies. The overall training paradigm will foster sustained establishment of
independent researchers in Kenya. Expansion of our highly successful training program in the next phase is
based on over $50M in annual funding for the multidisciplinary team assembled. The training platform will
provide transfer of technology and expertise to address the challenges of malaria, COVID-19, and other high-
burden infectious diseases in Kenya. Collectively, the overall approach will promote long-term capacity-building
and sustainability by establishing a critical mass of Kenyan scientists with the knowledge and skill sets necessary
to address the public health challenges facing their society.

Public health relevance
PROJECT NARRATIVE To meet the current and future challenges created by the leading infectious diseases in Kenya (e.g., malaria and COVID-19), we propose continuation of our research training program that has been continuously funded since being established in 2002. To maximize programmatic impact for training the next generation of Kenyan leaders, we have assembled a world-class team of multidisciplinary investigators from Kenya and Ghana who were former trainees in the program, along with long-standing partners at the University of New Mexico and Los Alamos National Laboratory. We propose advanced training in state-of-the art methodologies under the rubric of thematic target areas (Host-Pathogen Dynamics, Therapeutic Discovery, and Disease Modeling), strategically selected for maximizing long-term capacity building to combat high-burden infectious diseases in Kenya. ,